Designing a Hybrid Intervention Strategy to Reduce Alcohol Exposed Pregnancies Supplement

Prenatal alcohol exposure (PAE) increases the risk for Fetal Alcohol Spectrum Disorders (FASD). To address
this health threat, we propose an exciting collaboration between researchers at NYU, the University of Texas
Health Science Center-Houston, Purdue University, and CIFASD to develop, implement, and evaluate an alcohol
intervention for women in prenatal care. We propose a randomized controlled trial (N=600) to assess the efficacy
of the alcohol intervention, relative to usual prenatal care only, in reducing (1) women’s alcohol use and 2) poor
infant birth outcomes. We will recruit women at their first prenatal care visit. Eligibility criteria include (1) age >18
years; (2) ≤8 weeks gestation; (3) a positive rapid point-of-care ethyl glucuronide (EtG) urine test for recent
alcohol use or self-reported alcohol use in the prior three weeks, and (4) written informed consent. Eligible
women complete a baseline assessment by a Project Research Nurse (PRN) consisting of an ACASI and
collection of bloodspots for PEth analysis to assess alcohol consumption biologically. Subsequently, women are
randomized to either (1) the intervention condition, the usual prenatal plus the alcohol intervention, or (2) the
comparison condition, usual prenatal care only. Prenatal usual care involves clinicians assessing alcohol use
and counseling women on alcohol-related risks. The alcohol intervention consists of (1) a self-paced computer-
delivered component to enhance knowledge, norms, and motivation for alcohol reduction and (2) a PRN-
delivered component to reinforce the computer-delivered content and address women’s questions. Both
components are theory-driven, based on Motivational Enhancement Theory (MET), and use motivational
strategies to promote alcohol reduction. The alcohol intervention is developed with guidance from multiple
sources, including (1) the project’s Women’s Advisory Board; recruited from the proposed recruitment clinics
who self-report alcohol use during pregnancy, and (2) project investigators and consultants with extensive
experience and expertise in research and trial design, and developing and implementing SBIRTs for reducing
alcohol use and other drugs among women, including pregnant women. The alcohol intervention is delivered on
three occasions: (1) following the baseline and the 2nd- and 3rd-trimester assessments. Women randomized to
receive usual prenatal care only complete assessments on the same schedule as women in the intervention
condition. We will use generalized estimating equation models and an intent-to-treat analysis to evaluate the
efficacy of the intervention condition relative to the usual prenatal care condition in (1) increasing the proportion
of women detected with a laboratory-confirmed negative PEth test during pregnancy and (2) reducing the
proportion of adverse birth outcomes among infants. The proposed research is scientifically and clinically
significant. If demonstrated effective, the intervention may represent a scalable alcohol reduction strategy
suitable for prenatal clinical care in other maternity hospitals and clinical sites to reduce prenatal alcohol
exposure and adverse birth outcomes. If successful, this would be the first prevention intervention for CIFASD.

Public health relevance
This study develops, implements, and rigorously tests the effectiveness of a brief alcohol intervention in prenatal care. The objective of the alcohol intervention is to motivate women to reduce alcohol consumption during pregnancy. The study also assesses whether the intervention reduces adverse birth outcomes.